IGF::OT::IGF OTHER FUNCTIONS. Applied Research Program (ARP) Meeting and Working Group Support. POP 1/1/18 - 12/31/18.

The objective of this task order is to provide high level professional support in specific areas across DCCPS, including workshops and seminars, materials development, and writing and editorial activities